Single-cell Epigenome Analysis of the Alzheimer's Disease Brain

Project Summary
Late onset AD (LOAD) is a heterogeneous disease that involves complex interactions between genetic,
epigenetic, and environmental risk factors. Genome-wide association studies (GWAS) have identified several
thousand sequence variants linked to increased or decreased risk of AD, most of which are noncoding. The
current paradigm posits that noncoding variants contribute to disease etiology by perturbing transcriptional
regulation in disease-relevant cell types, while environmental risk factors contribute to pathogenesis in part via
alterations to the epigenome. However, a lack of maps and tools to explore gene activities and their
transcriptional regulation at cellular resolution in the brain has presented a major bottleneck to the functional
interpretation of noncoding AD risk variants. In prior work, we applied Droplet Paired-Tag multi-omic profiling of
transcription and histone post-translational modification to post-mortem AD and control parietal cortex,
demonstrating its capacity to profile cellular epigenetics and transcription from bulk samples. This technology
has garnered significant interest through our early-access program. In the proposed study, we will develop a
manufacturing quality management system incorporating references and reference measurements for the
production of Droplet Paired-Tag Kits. We will optimize our protocols specifically on post-mortem AD and
healthy brain tissue from hippocampus, white matter, and cerebellum, as well as on peripheral blood; and
further optimize Droplet Paired-Tag for application to sorted nuclear populations. We will publish the resulting
data as a comprehensive cellular encyclopedia of DNA elements. If successful, the research would catalyze
the study of the epigenetics of AD, and enable the widespread application of next-generation multi-omic assays
to AD and other neurological diseases.

Public health relevance
Project Narrative We proposed to optimize Droplet Paired-Tag multi-ome kits for histone/TF profiling by incorporating reference materials, spectra, and quality management practices into our manufacturing process. We further proposed to extensively validate these kits by profiling four histone marks in three regions of AD and normal post-mortem brains (hippocampus, white matter, and cerebellum) and on sorted cell populations from these regions, generating multi-regional epigenetic maps of AD and normal brain. By providing both initial data and the kits necessary to expand the resource, we hope to catalyze the study of cellular AD epigenetics.